TRIAL OF 2 DOSES OF 2', 3'DIDEOXYINOSINE (DDI) IN CHILDREN UNRESPONSIVE TO AZT

The purpose of this study is a randomized comparative trial of 2 doses of 2',3' dideoxyinosine (ddI) in children with symptomatic HIV infection who are either unresponsive to Zidovudine (AZT) and/or who are intolerant to zidovudine.